Administrative Core

REVISED PROJECT SUMMARY – ADMINISTRATIVE CORE (AC) The Administrative Core (AC) of the New Mexico Alzheimer’s Disease Research Center (NM ADRC) coordinates all activities and ensures the cohesiveness of the 7 cores and one component. Individuals in the AC have been working together in the exploratory NMeADRC. The AC formed critical partnerships to improve dementia diagnosis and care in the urban and rural Hispanic/Latino (H/L) and American Indian (AI) communities. Zuni Pueblo is an example of a rural medically underrepresented population a long distance from a major medical center. We overcame the barriers of distance by using a mobile scanner to perform on-site MRI studies and with Community Health Representative doing neuropsychological testing. We formed a partnership with the New Mexico state Aging and Long-Term Services Department to expand dementia care by training community based social workers with ECHO telehealth resources. Those identified as at risk for AD will undergo further studies at the UNM Center for Memory and Aging (CMA). The AC will establish committees and hold regular meetings of the Executive Committee composed of the Core leaders to address problems. We will continue to send demographic, clinical, biomarker and imaging data to the national repositories. Training the next generation of AD scientists will be done with developmental grants that will be awarded to two early-stage investigators. The AC formed partnerships with other research centers in the university and around the state to promote AD/ADRD research. The AC organized a highly successful research symposium that highlighted research at NM ADRC and other sites. The AC was important in developing the framework for the P30 grant and identifying strong core leaders from other departments in the university. The day-to-day operation of the NM ADRC will be done by the AC in consultation with the core leaders. New Mexico is a “frontier” state with a large land mass and a sparse, scattered population. The UNM CMA is the only center for dementia care in the Rocky Mountain region and the NM ADRC will be the first such center in an area extending from Mexico to Canada. It will bring advanced dementia research, such as plasma-based biomarkers and advanced MR imaging to rural areas to identify individuals at risk for AD who could benefit from the emerging treatments for dementia. The AC will oversee research in the NM ADRC on the role of inflammation and patient classification methods based on machine learning, starting to bring concepts of precision medicine to rural communities.